Mutations in Osteoprotegerin Cause Calcium Pyrophosphate Deposition Disease

Calcium pyrophosphate deposition disease (CPDD) is a common type of arthritis defined by the
presence of calcium pyrophosphate (CPP) crystals in articular cartilage. It is particularly
common in the US Veteran population as risk factors for CPDD including advanced age and
prior joint trauma are highly prevalent in American Veterans. We recently published a study of
US veterans using ICD-9 codes to identify 29,000 American Veterans with the disease in a
single 5-year period. While CPDD affects elderly patients in a sporadic fashion, it also occurs
prematurely in familial patterns. Studies of familial forms of this disease present exciting
opportunities to identify novel therapeutic targets for this currently untreatable arthritis. We
recently confirmed that a mutation in the stop codon of TNFRSF11B causes early onset CPDD.
TNFRSF11B codes for osteoprotegerin (OPG). The OPG mutation causing CPDD (mtOPG)
results in an additional 19 amino acids added to the protein's C terminus near the heparin
binding domain. OPG is decoy receptor for receptor activator of nuclear factor kappa B ligand
(RANKL). RANKL promotes osteoclast formation, and because OPG blocks its function,
reduction of OPG activity results in increased osteoclastogenesis. The phenotype of affected
patients with this mutation includes exuberant CPP crystal formation, mild osteopenia and
severe joint degeneration, a phenotype consistent with a loss of function of OPG. Indeed,
preliminary data demonstrate that recombinant mtOPG displays inefficient inhibition of
membrane-bound RANKL resulting in excess osteoclastogenesis in vitro. Interestingly,
osteoclast conditioned media potently stimulates biomarkers of CPP crystal formation in
chondrocytes. The purpose of this work is to investigate the conceptually innovative
hypothesis that mtOPG produces CPDD by increasing osteoclastogenesis in
subchondral bone. In specific aim 1, using in vitro and in vivo models, we will show that
compared to wild type OPG (wtOPG), mtOPG ineffectively binds to the osteoblast cell
membrane. resulting in excess un-opposed membrane-bound RANKL and increased osteoclast
formation. Overabundant osteoclasts in subchondral bone produce joint damage and release
CPP crystal-promoting factors into articular cartilage. In the second aim, structural studies using
chromatography, surface plasmon resonance and small angle x-ray scattering, will demonstrate
reduced affinity of mtOPG to bind heparan sulfate and decreased dimerization. The scientific
premise of this work stems from careful observations of the phenotype of patients with the OPG
mutation and is supported by preliminary in vitro functional studies of mtOPG. These studies are
the first to identify the OPG/RANKL/RANK pathway in CPDD and to implicate subchondral bone
as a target tissue in this disease. The shared clinical features of patients with CCAL1 and those
with sporadic CPDD as well as the existence of available drugs which target this pathway make
this work particularly exciting.

Public health relevance
Calcium pyrophosphate deposition disease (CPDD) is a painful form of arthritis which is common among US veterans. Risk factors for CPDD include advanced age, and prior joint trauma which are common characteristics of the veteran population. Its cause is currently unknown and there are no specific or effective therapies for this painful arthritis. This work explores the role of a protein called osteoprotegerin in CPDD. Genetic abnormalities in this protein were identified as one cause of this disease. In this proposal will explore the mechanisms through which genetic abnormalities in osteoprotegerin cause CPDD, with the ultimate goal of developing new therapies for all patients with CPDD.